Periodontal Regeneration with Supramolecular Nanomaterials

PROJECT SUMMARY/ABSTRACT
Periodontal disease is a chronic infection that results in the host inflammatory responses destroying the
periodontal ligament, cementum, alveolar bone and gingiva that anchor the tooth in the jaw. Previous studies
have shown that periodontal ligament cells (PDLCs) can be directed to differentiate to osteoblasts, fibroblasts
and cementoblast-like cells in vitro and in vivo. The canonical Wnt/β-catenin signaling pathway has been
demonstrated to stimulate cell proliferation and osteogenic differentiation of PDLSc. Wnt signaling is required for
periodontal homeostasis. Lastly, a commercial product Emdogain, consisting largely of alternatively spliced and
processed porcine amelogenins, was shown to induce bone, cementum and periodontal ligament regeneration
in primates and humans. We sought to identify the biologically active peptide(s) in Emdogain responsible for
activating these differentiation pathways, anticipating such bioactive molecules would make possible a much
more targeted approach to periodontal tissue regeneration. We have identified one of the amelogenin splicing
isoforms, Leucine-rich Amelogenin Peptide (LRAP) to induce osteogenesis in various adult and embryonic stem
cell types. Moreover, LRAP is expressed in the periodontium, with cementum defects and enhanced
osteoclastogenesis being observed around tooth roots of amelogenin knockout mice which lack LRAP
expression. LRAP treatment significantly reduces the expression of RANKL, a key regulator of
osteoclastogenesis, in periodontal ligament cells. Furthermore, LRAP stimulates the proliferation and migration
of periodontal ligament cells, as well as affects bone turnover in vivo. Cell signaling involves not only the binding
of growth factors and cognate receptors, but also their clustering on the cell membrane. However, little or no
work has been directed thus far toward investigating how biomaterials can serve to enhance growth factor or
peptide signaling by increasing diffusion of cell surface receptors within membrane lipid rafts. Therefore, a better
understanding of the cellular and molecular mechanism(s) operating at the material-cell membrane interface
during cell signaling has the potential to change the paradigm in designing future biomaterials and regenerative
medicine therapeutics. Previously, we discovered that peptide amphiphile (PA) nanofibers with controlled
supramolecular β-sheet cohesion could alter cell membrane raft mobility, resulting in enhanced osteogenic
signaling. Recently, we have developed a PA molecule with a cholesterol tail to potentiate canonical Wnt receptor
signaling by modulating lipid raft/caveolar dynamics. In this proposal, we will test the hypothesis that the effect
of LRAP on periodontal tissue regeneration is mediated by activating the canonical Wnt/β-catenin signaling
pathway and the signaling effect can be potentiated by PA molecules through increased receptor sensitivity.
Combining PA molecules with the small peptide LRAP may afford more effective interventional strategies to
clinicians for regeneration of tooth supporting tissues lost to periodontal disease.

Public health relevance
PROJECT NARRATIVE The goal of this project is to characterize the therapeutic effect of supramolecular nanomaterials on potentiating the signaling effect of a naturally occurring small peptide on periodontal tissue regeneration